Local Delivery of CCL2 to Reverse Peri-implant Bone Loss in Murine Peri-implantitis

PROJECT SUMMARY
In the United States, 3 million people have received dental implants, and it is predicted that 500,000 dental
implants will be newly placed every year. While dental implants have been a popular option to replace lost teeth,
peri-implantitis (PI) is getting more prevalent, affecting 24% of dental implant patients. PI is an oral inflammatory
disease causing soft and hard tissue breakdowns around dental implants. PI is challenging to treat because of
its irreversible aspect, aggressive progression, and difficulty in cleaning implant surface. The current treatment
modalities for PI are mainly limited to surgical interventions, which are generally more invasive, painful, and time-
intensive. Moreover, these treatments fail to address the host’s uncontrolled immune response and subsequent
microbial dysbiosis. In light of previous studies showing that altered host-microbiome interactions may play key
roles in PI pathogenesis, I propose to study immunomodulatory strategies as potential treatment options. The
objective of this study is to determine the protective role of the C-C motif chemokine ligand 2 (CCL2) on host-
microbiome interactions through direct polarization of macrophages into M2-like anti-inflammatory phenotypes.
The murine ligature-induced PI is used as a model for an inflammatory disease where tissue destruction is driven
by a breakdown of host-microbe homeostasis. In this study, I hypothesize that the local delivery of CCL2-
releasing microparticles (CCL2 MPs) into peri-implant tissues will restore the balance of M1/M2 by polarizing
macrophages to M2-like phenotype, create an anti-inflammatory environment, and reverse disease-associated
microbial changes in PI. This proposal aims to 1) unravel the immunomodulatory effects of CCL2 on immune
cells and their downstream pathways and 2) determine the effects of CCL2 on disease-associated bacteria and
microbial dysbiosis. In aim 1, the murine ligature-induced PI model will be used with or without local delivery of
CCL2 MPs. Then, single-cell RNA sequencing (scRNA-seq) will be performed to acquire in-depth data about the
PI pathogenesis and mechanistic CCL2’s function on immune cells by evaluating pathways and differentially
expressed genes. In addition, scRNA-seq data will be complemented by Flow Cytometry data. In aim 2, 16S
rRNA gene sequencing analysis on peri-implant plaque buildup will be conducted to assess CCL2’s therapeutic
effects on PI-related bacterial species and microbial dysbiosis by modulating the host’s inflammatory response.
I will evaluate the total bacterial load and shifts in microbiome compositions with or without CCL2 MPs. The
overall goal of this proposal is to challenge the unmet need for effective therapies to treat PI by applying a novel
immunomodulatory therapy. Successful completion of this proposed study will expand our understanding of PI
pathogenesis and support the therapeutic potential of local immunomodulation in PI.

Public health relevance
PROJECT NARRATIVE We propose to restore the balance of M1/M2 macrophages in peri-implantitis and create an anti-inflammatory environment by inducing M2 polarization using immunomodulatory therapy. This study will provide critical mechanistic data about the pathogenesis of peri-implantitis and the protective role of chemokine CCL2.